Mechanism of Manganese-induced neurotoxicity via microglial Leucine Rich Repeat Kinase 2 (LRRK2)

Project Summary
Chronic exposure to elevated manganese (Mn) levels in occupational/environmental settings causes a
neurological disease referred to as manganism, a Parkinson's disease (PD)-like symptoms, but its toxicity
mechanisms are not completely understood. Leucine-rich repeat kinase 2 (LRRK2) is a large multidomain protein
that includes a kinase domain. Although the LRRK2 function is not fully understood, its kinase activity has been
implicated in vesicle trafficking and autophagy. Intriguingly, certain environmental toxicants, such as the pesticide
rotenone, increase LRRK2 kinase activity. Furthermore, the LRRK2 mutation in G2019S, which is most
frequently linked to familial PD, exerts LRRK2 hyper-kinase activity. These indicate that elevated LRRK2 kinase
activity is common in both environmental toxicants-induced wild-type (WT) and G2019S mutation. There is strong
evidence that LRRK2 kinase is increased by certain environmental toxicants, such as rotenone. Importantly, we
found that Mn increased LRRK2 expression and its kinase activity in both WT and G2019S mouse brains as well
as microglial culture. Given that both Mn and LRRK2 modulate microglial proinflammatory responses, microglial
LRRK2 may mediate Mn-induced neurotoxicity. 14-3-3 proteins, which are highly conserved regulatory proteins,
are known to interact with LRRK2 and decrease its kinase activity. Notably, Mn decreased 14-3-3 expression
and its interaction with LRRK2, which was further pronounced in G2019S. The downstream pathological
mechanism(s) of this Mn-increased LRRK2 may include impairment of mitochondrial fission-fusion, lysosomal
defects, and mito/autophagy as both Mn and LRRK2 are involved in these processes. Our central hypothesis is
that Mn-induced LRRK2 hyper-expression/kinase activity in microglia leads to impairment of mitochondrial
fission-fusion, lysosomal function, and mitophagy, with subsequent increase of inflammasome and cytokines,
resulting in neuronal injury by exosome and paracrine modes. The hypothesis will be tested by 3 Aims. Aim 1
will investigate the mechanisms of Mn-induced LRRK2 upregulation and kinase activity via YY1 and Sp1, as well
as dysregulation of 14-3-3s and their binding to LRRK2 in microglia. Aim 2 will investigate the downstream
toxicity mechanisms of Mn-increased microglial LRRK2 kinase and subsequent neuronal injury in a microglia-
neuron coculture system. Whether all these effects are exacerbated in G2019S due to LRRK2 hyper-kinase
activity will also be tested. Aim 3 will test if microglial LRRK2 kinase activity is critical for Mn-induced neurotoxicity
in in vivo mouse models. We will test the role of microglial LRRK2 in Mn-induced motor deficits in mice using
pharmacological and genetic approaches. The outcome of the proposed studies will be highly impactful as we
will identify cellular and molecular targets of Mn toxicity mechanisms via microglial LRRK2, thus contributing to
the development of therapeutic strategies for Mn toxicity. Moreover, our findings will also provide invaluable
insights into how Mn and other environmental neurotoxins that increase LRRK2 kinase activity could be a
potential risk factor for the development of LRRK2-associated PD.

Public health relevance
Project Narrative Chronic exposure to elevated manganese (Mn) levels causes a neurological disease, but the mechanism for Mn-induced neurotoxicity is yet to be established. Parkinson’s disease (PD)-related gene Leucine-Rich Repeat Kinase 2 (LRRK2) appears to play a critical role in Mn-induced neurotoxicity, possibly by Mn-induced LRRK2 hyper-kinase activity, which is further exacerbated in G2019S mutated LRRK2 in microglia, suggesting that the LRRK2 hyper-kinase activity could be a pivotal toxicity mechanism of Mn-induced neurotoxicity. Thus, the current proposal will investigate the comprehensive neurotoxic mechanisms involved in Mn-induced LRRK2 hyper- kinase activity, and its cellular and molecular targets for the development of therapeutic strategies to treat Mn toxicity as well as neurological disorders associated with hyper-LRRK2 kinase activity.